Understanding pathogen and host determinants of the natural history of N. gonorrhoeae infection

Abstract:
Rising antibiotic resistance in N. gonorrhoeae poses a serious, global public health threat.
Effective control of N. gonorrhoeae is hampered by asymptomatic infections that allow
transmission of the bacteria to uninfected individuals and immune evasion by the bacteria that
has limited vaccine development efforts. Understanding the natural history of asymptomatic
infection and the immunologic responses that are responsible for clearance of infection. We
propose a longitudinal study with close surveillance and of follow up individuals with recent N.
gonorrhoeae infection who are at high risk for re-infection. This study will provide a rich data
set to understand pathogen exposure and infection outcome. It will also provide a set of biologic
specimens to study the pathogen and host factors that contribute to infection clearance as well
as asymptomatic carriage and/or progression to symptomatic infection. We will conduct
analysis of anti-N. gonorrhoeae antibody and cellular immune responses to inform correlates of
protective immunity against gonorrhea. Combined this project will provide important new
information that will contribute to public health and vaccine development efforts to reduce the
spread of N. gonorrhoeae.

Public health relevance
Project Narrative Rates of sexually transmitted infections with Neisseria gonorrhoeae are rising in the US and increasing gonococcal antibiotic resistance presents a major public health threat. Inadequate understanding of the natural history of infection is a substantial impediment to the development of public health interventions against gonorrhea, particularly vaccines. This study proposes a novel longitudinal study of N. gonorrhoeae natural history in a high-risk cohort to identify the bacterial and host determinants of infection outcome using the distinct, yet integrated, strategies of pathogen and natural microbial community genomics and immunology.